Mechanisms and Consequences of c-di-GMP Control of Motility and Biofilm Formation

PROJECT SUMMARY
Biofilms, surface-attached microbial communities encased in an extracellular matrix, enhance the environmental
survival, transmission, pathogenicity, and antibiotic resistance of pathogenic microorganisms. A key regulator of
biofilm formation in bacteria is the broadly conserved nucleotide-based second messenger, cyclic dimeric
guanosine monophosphate (c-di-GMP). c-di-GMP is produced by diguanylate cyclases (DGCs), degraded by
phosphodiesterases (PDEs), and sensed by c-di-GMP receptor proteins. This proposal examines the molecular
mechanisms and consequences of biofilm formation in Vibrio cholerae, the bacterium causing the disease
cholera, an important public health problem worldwide. While interfering with biofilm formation might mitigate the
global health impact of diseases like cholera, how c-di-GMP controls this process remains unclear. Our objective
is to address major gaps in our understanding of the interplay between the flagellum, pili, and c-di-GMP in the
motile-to-sessile switch, biofilm formation, and V. cholerae infection. Specific Aim 1 focuses on determining how
c-di-GMP and specific DGC and PDE proteins modulate the torque-speed relationship of the sheathed flagellum
in V. cholerae using biophysical approaches and novel reporters to quantify c-di-GMP levels. We will also
examine how c-di-GMP receptor proteins, particularly PilZ domain proteins, regulate motility and biofilm
formation through genetic, biochemical, and structural analyses. Specific Aim 2 examines the molecular
mechanism(s) through which c-di-GMP controls the production and activity of the mannose-sensitive
haemagglutinin type IV pili (MSHA), the primary mediator of initial surface attachment, which leads to biofilm
formation, using structural and biochemical approaches. Specific Aim 3 dissects the role of c-di-GMP signaling
in V. cholerae infection using state-of-the-art imaging tools and novel c-di-GMP sensors. This research promises
molecular and mechanistic insights into c-di-GMP signal transduction pathways governing motility and biofilm
formation, ultimately allowing us to devise ways to inhibit V. cholerae infection cycle. Understanding these
mechanisms will also lead to new strategies for disrupting biofilms and controlling motility in other pathogens,
thereby improving treatments for biofilm-related bacterial infections.

Public health relevance
PROJECT NARRATIVE Infectivity and transmission of Vibrio cholerae, the causative agent of cholera, are significantly enhanced by its ability to form and survive in matrix-enclosed multicellular communities known as biofilms. In V. cholerae, the signaling molecule c-di-GMP is crucial for modulating bacterial motility and biofilm formation through poorly understood signaling pathways. This proposal aims to elucidate these pathways and determine their impact on the V. cholerae infection cycle to uncover mechanisms supporting the development of novel therapeutics to attenuate V. cholerae biofilm-associated infections and, potentially, those caused by other pathogenic bacteria.